Mechanisms of trans-synaptic pathological tau spreading in the human brain

PROJECT SUMMARY
The incidence of Alzheimer’s disease (AD) is on the rise, and we are in dire need of effective
treatments. In AD, the spatiotemporal progression of tau pathology within the CNS remains the strongest
neuropathological correlate of cognitive impairment, thus constituting a likely effective treatment target (long-
term goal). Compelling evidence supports a trans-synaptic framework for pathological tau spreading, driven
primarily by the propagation of toxic soluble tau oligomer (tauO) conformers between functionally connected
brain regions. Numerous investigations further postulate the influence of amyloid-beta (Aβ) on trans-
neuronal pathological tau spreading, while emerging evaluations of primary tauopathies (e.g. Primary Age
Related Tauopathy—PART), which lack Aβ, observe limited regional tau spreading alongside little-to-no
amnestic changes. Within the trans-synaptic spreading framework, however, the precise mechanisms by
which tauO engage human synapses, and the role of Aβ in this process, remain unknown. We thus
hypothesize that Aβ modulates pathological tau spreading by increasing oligomeric tau binding to vulnerable
synapses. To support this hypothesis, we provide novel preliminary evidence for two (i.e. bivalent) tauO
binding sites in human synapses and further show that synaptic tauO binding is significantly increased in
the presence of soluble Aβ oligomers. In Aim 1, we will characterize the molecular mechanisms underlying
bivalent tauO binding, as a function of AβO, in healthy human synapses. In In Aim 2, we will evaluate how
AβO, or lack thereof, influences synaptic tauO binding as a function of regional (i.e. hippocampus vs.
neocortex) and clinical (PART vs. AD) resilience status. To execute these aims, we have developed an
innovative and translationally relevant approach to interrogate mechanisms of tau binding directly in human
synapses isolated from post-mortem autopsy specimen using an array of biochemical techniques. At the
completion of this project, we expect to document previously unappreciated mechanisms that modulate
synaptic tauO binding—a key component of pathological tau spreading. In addition to advancing our
understanding of human tauopathies, I also look forward to sharpening my understanding of human synapse
biology, learning to integrate molecular biology research techniques with clinical neuropathology, and
planning and executing translationally relevant research objectives. A uniquely qualified team of established
research and clinical mentors at The University of Texas Medical Branch have been assembled to effectively
guide my training through this project, bringing together expertise in AD molecular neurobiology (Dr.
Taglialatela), amyloid biochemistry (Dr. Kayed), human synaptic physiology (Dr. Limon), neurology (Dr.
Fang), and neuropathology (Dr. Felicella). The comprehensive training plan outlined herein will provide
essential technical, intellectual, and professional skills to help me achieve my long-term career goals as an
academician and physician-scientist.

Public health relevance
PROJECT NARRATIVE In Alzheimer’s disease (AD), predictable spreading of tau pathology between functionally connected brain regions correlates well with progressive cognitive impairment, thus constituting a likely effective treatment target. The proposed study will evaluate the molecular mechanisms of pathological tau spreading within the framework of trans-synaptic tau spreading. Specifically, the results of this investigation will contribute to the fundamental knowledge about the molecular mediators of tau oligomer binding in human synapses, thus providing novel and translationally relevant avenues for future AD research.